Quadrupole-Orbitrap Mass Spectrometer

PROJECT SUMMARY/ABSTRACT The University of Colorado Medical Schools Mass Spectrometry Facility is requesting funds for the purchase of a quadrupole high?field orbitrap mass spectrometer and liquid chromatography system to support the research of NIH funded investigators. Research projects and preliminary data from eleven major users with over 20 active NIH funded grants cover analytical needs to advance numerous basic science, translational and clinical research projects. These projects cover a number of biomedical research areas including cancer (development, progression and therapy), pulmonary hypertension, transfusion medicine, and basic biomedical science. Current instrumentation is not meeting the needs of the investigators due to inadequate instrument time available and the need for improved capabilities. The requested instrument will provide high mass accuracy, high sensitivity and rapid scan rates for the detailed characterization of small molecule metabolites and protein digests. This information will be used to perform quantitative and flux analysis for metabolic pathways involved in disease, as well as for discovery mode metabolomics purposes. Likewise, quantitative and qualitative protein analyses will contribute to the discovery and validation of protein alterations, signaling pathways and protein?protein interactions. Additional investigators working on important biomedical questions will be able to gain access to the proposed instrumentation through the Mass Spectrometry Facility. Having the system located in a shared resource that houses the Proteomics & Metabolomics Cores will facilitate further collaboration and optimal usage. The Facility receives strong institutional support through expert oversight and financial commitment to ensure long?term utilization of instrumentation. The proposed mass spectrometer will enable team science aimed at achieving the goals of numerous NIH funded investigators.

Public health relevance
PROJECT NARRATIVE The proposed mass spectrometer will provide multiple NIH funded investigators with the analytical capabilities to answer challenging questions aimed at the improvement of human health. The instrumentation used to study metabolites and proteins in biomedical samples have undergone a revolutionary leap in performance. These advancements will facilitate new discoveries to improve our understanding of disease at the molecular level.